GLUTAMINE SUPPLEMENTATION IN INFANTS AND CHILDREN WITH SHORT BOWEL SYNDROME

Supplementation of parenteral nutrition infusates (PN) with glutamine (GLN) in infants and children with short bowel syndrome will result in clinical benefits that include improved tolerance of enteral feeds, and a reduced incidence of bacteremia.